Driving community-centered medical device innovation via a longitudinal interdisciplinary immersion program

Project Summary
Implicit bias is a well-documented contributor to healthcare disparities that lead to poorer health
outcomes, higher infant mortality rates, and chronic disease in racial and ethnic minority populations.
There exists a clear and critical need to reimagine how we approach engineering training to improve
cultural competency and facilitate patient-centered, economical solutions accessible by all people
regardless of race and socioeconomic status. Barriers to paradigm change are entrenched in the ways in
which we equip clinicians to care for patients and train engineers to create solutions for clinicians. Our
long-term goal is to establish an interdisciplinary, team-based approach for training engineers and
clinicians to identify and address barriers to medical care and efficiency. The short-term objective of this
proposal is to establish a two-year community-centered medical device innovation program that leads to
creative, interdisciplinary problem-solving. The program foundation is supported by three specific aims. Aim 1.
Establish a pedagogy that fosters creativity and flexibility in problem-solving of community-based medical
needs through multidisciplinary clinician-engineering design teams. Aim 2. Emphasize impactful, financially
sustainable, and commercializable solutions based on community need as a model for improving accessibility
to care for historically marginalized groups. Aim 3. Improvement of recruitment and retention of students from
underrepresented groups to increase the diversity of the biomedical engineering workforce pipeline. The
program will recruit 75% of students from underrepresented groups in STEM. Design teams formed by
engineering and nursing students will be exposed to the continuum of the design arc through community-
centered, patient-centered needs finding, courses in medical device design and regulation as well as
considerations for product development and entrepreneurship. Importantly, design teams interdisciplinary
training focuses on identifying medical need through direct observation and immersion into the
community medical system. The design and entrepreneurship experience of the students from problem
identification to medical device commercialization will be supported by the biotech incubator
Massachusetts Medical Device Development Center, a Medical Device Development Steering
Committee, and the Center for Community Research and Engagement. The program’s effectiveness in
training students to identify and address barriers to medical care and efficiency, learning of the material,
changes in behavior, and program implementation will be assessed by the Center for Program
Evaluation. The proposed program will immediately and directly impact the training and development of
the biomedical engineering and nursing workforce through multi-disciplinary collaboration and clinical
immersion to facilitate patient-centered design thinking.

Public health relevance
Project Narrative Implicit bias is a well-documented contributor to healthcare disparities that lead to poorer health outcomes, higher infant mortality rates, and chronic disease in racial and ethnic minority populations. There exists a clear and critical need to reimagine how we approach engineering training to improve cultural competency and facilitate patient-centered, economical solutions accessible by all people regardless of race and socioeconomic status. The objective of this proposal is to establish a community- centered medical device innovation program that leads to creative, interdisciplinary problem solving of multidisciplinary engineering-nursing design teams.